PRINT: Nanoparticles: "Calibration Quality" Nano-tools for Studying the Effect of

Project 1: PRINT Nanoparticles:

Public health relevance
The utilization of nanocarriers for the delivery of therapeutics has led to a significant decrease in the toxicity of chemotherapeutics and point to the potential of nanoparticle based therapies to improve cancer treatment. Current research, including the research proposed in this application, is focused on developing nanoparticle carriers that can improve the therapeutic efficacy as well as further lower the toxicity of small molecule cytotoxins as well as allow for the effective delivery of fragile biologies like siRNA.